LifeBio Memory: Development of a reminiscence therapy online platform with machine learning to increase engagement

Short Summary Statement
This resubmission proposal (originally scored 36) aims to investigate the effectiveness of LifeBio
Memory (LBM) technology, enhanced with Artificial Intelligence (AI) capabilities, in improving
health-related quality of life, depression, relationship closeness, and loneliness among older
adults with mild cognitive impairment (MCI) or at risk of MCI and their informal caregivers. The
LBM technology has been shown to increase engagement with reminiscence therapy, but its
efficacy across diverse linguistic and cultural backgrounds remains untested.
To address this gap, we will extend our investigation to include participants from various racial
and ethnic groups using a mixed-methods approach. A significant innovation of this study is the
integration of AI-powered voice technology, enabling the LBM system to learn and replicate an
individual's unique vocal characteristics, creating a deeply personal and immersive experience.
The study consists of three aims:
1. Develop and refine LBM's multi-language support, including Spanish, Korean, and
English for African-American populations, with a focus on incorporating AI-driven voice
clone capabilities and culturally relevant presentation.
2. Conduct usability testing with 48 participants to assess the learnability, efficiency, error
recovery, and subjective satisfaction of the LBM app and AI voice clone feature.
3. Test the feasibility, acceptability, and initial efficacy of the LBM intervention using a
randomized waitlist-controlled trial among 84 diverse racial and ethnic dyads.
We will evaluate outcomes at baseline, 6 weeks post-follow-up, and 10 weeks post-follow-up,
assessing health-related quality of life, depression, relationship closeness, and loneliness using
standardized measures. We will examine the impact of the AI-powered voice clone feature on
user engagement, emotional response, and overall satisfaction with the LBM experience.
This study has significant scientific merit, addressing a critical gap in literature by investigating
the effectiveness of LBM among diverse populations and exploring the potential benefits of AI-
driven voice clone technology. The results will inform the development of culturally sensitive
interventions to support older adults with MCI or at risk of MCI and their caregivers, potentially
leading to innovative, personalized therapies that improve health outcomes and reduce
healthcare disparities. If successful, this intervention could offer invaluable non-pharmacological
support, warranting widespread implementation through home and community-based services.

Public health relevance
Project Narrative: This proposal aims to improve and evaluate LifeBio Memory (LBM) technology, enhanced with AI, in improving health-related quality of life, depression, relationship closeness, and loneliness among older adults with mild cognitive impairment (MCI) or at risk of MCI, and their caregivers. The study will include diverse racial and ethnic groups and leverage AI-powered voice technology for a personalized reminiscence therapy experience. Key aims include developing multi-language support, conducting usability testing, and assessing the intervention’s initial effectiveness in a randomized, waitlist-controlled trial.